High-Resolution Bidirectional Optical-Acoustic Mesoscopic Neural Interface for Image-Guided Neuromodulation in Behaving Animals - RF1 Admin Supplement

ABSTRACT
Neuroscience has an essential requirement for large-scale imaging and perturbation tools.
Such tools would be transformative in the mapping of brain function and the diagnosis and
treatment of neurological disorders. The proposed project is aimed at uncovering regulation of
glymphatic and vascular flow in the progression of Alzheimer’s disease (AD) at whole-brain,
cellular-resolution scales using novel whole-brain imaging modalities. Our project’s goal is to use
state-of-the-art in vivo imaging techniques to study cerebrospinal fluid (CSF) flow in the brain, and
how this flow interacts with AD-related protein accumulation in transgenic models. We will study
how flow in this system is perturbed in AD, with a focus on clearance of waste products

Public health relevance
Narrative The high tissue penetrability of ultrasound (US) waves presents untapped and exciting opportunities for accessing structures throughout the mammalian brain for therapeutic purposes. In this project, we will use whole-brain optoacoustic imaging to investigate the effects of Alzheimer’s disease (AD) on cerebrospinal fluid (CSF) flow in the brain in conjunction with AD- related protein aggregation imaging, building upon unique experimental tools developed in our lab. We will use this imaging modality to examine modulation of CSF and vascular flow and its interaction with AD-related protein clearance.